Learning Health systems training to improve Disability and chronic condition care (LeaHD)

ABSTRACT: OVERALL
Rehabilitation and long-term services and supports (LTSS) are high-value, effective interventions for improving
the lives of persons with disability and chronic conditions. As with most health care, inequities in access to and
quality of rehabilitation and LTSS exist. Efforts to address these inequities have never been more important,
given that chronic conditions affect more than half of U.S. adults, with 27% having multiple chronic conditions
(MCC), and one in four US adults living with a disability. MCCs are associated with preventable and high
healthcare costs, hospitalizations, emergency department utilization, and disability. Chronic conditions are
costly, accounting for 75% of US healthcare dollars. Furthermore, the proportion of persons living with MCC
and/or disability is steadily increasing, disproportionately affecting persons 65 years and older, those living in
poverty, and those from some racial or ethnic minority groups. A learning health systems (LHS) approach
offers potential solutions to minimizing disparities in rehabilitation and LTSS, by embedding knowledge and
best practices into care delivery, thereby supporting improvement, innovation, and equity. This application
seeks to create the Learning Health systems training to improve Disability and chronic condition care (LeaHD)
center which will build upon an established, NIH-funded P2C resource center, the Learning Health Systems
Rehabilitation Research network (LeaRRn). LeaHD’s long term goal is to improve the health-related quality of
life of persons with disability and chronic conditions by improving access to and quality of rehabilitation and
LTSS. Our overarching objective is to train embedded scientists to conduct PCOR/CER and dissemination and
implementation (D&I) research that will inform improvements in health system operations, quality of care, and,
thus, health outcomes for persons with disability and chronic conditions. LeaHD will build upon a well-
established infrastructure and collaborative relationships at Brown University, University of Pittsburgh, and
Boston University, faculty expertise and nine health system partners. Our specific aims are to: 1) establish
meaningful and inclusive health system partnerships to identify and develop important questions focused on
rehabilitation and LTSS for persons with disability and chronic conditions; 2) recruit and develop a diverse
cadre of highly-skilled scientists poised to conduct embedded research; 3) leverage existing resources to
provide mentored training for embedded scientists through core LHS research training, individualized training
plans, and experiential learning; 4) facilitate embedded PCOR, CER, and D&I research through mentorship
and methodological and operational expertise and support; and 5) utilize a comprehensive evaluation
framework to assess LeaHD’s impact on embedded scientist professional development, health systems
operations, and individual, family, and community-level outcomes.

Public health relevance
PROJECT NARRATIVE: OVERALL The Learning Health systems training to improve Disability and chronic condition care (LeaHD) center will train embedded scientists to conduct PCOR/CER and dissemination and implementation research that will inform improvements in health system operations and quality of care. LeaHD will train a cadre of learning health systems (LHS) scientists who will be poised to transform the delivery, quality, and outcomes of care for persons with disability and chronic conditions by focusing on rehabilitation and long term services and supports (LTSS). LeaHD will build upon a well-established infrastructure and collaborative relationships between Brown University, University of Pittsburgh, and Boston University, extensive faculty expertise, and established and emerging partnerships with a diverse group of nine health system partners.